Regulation of the Vibrio cholerae MSHA Pilus Drives Host Colonization and Pathogenesis

PROJECT SUMMARY/ABSTRACT
Development of multicellular biofilm communities is vital to the lifecycle of many bacterial species. Biofilm
formation begins with the attachment of a motile bacterium to a surface, though the underling mechanisms that
regulate surface attachment in most biofilm-forming bacterial species remain to be elucidated. For the pandemic
cholera pathogen Vibrio cholerae, proper regulation of the type IV mannose-sensitive hemagglutinin (MSHA), is
a key factor for mediating the transition from environmental colonization to host infection and pathogenesis.
MSHA pilus production is essential for V. cholerae environmental surface attachment and biofilm formation, but
cell-surface exposure of MSHA pili in the host results in bacterial clearance, preventing host infection and
pathogenesis. In V. cholerae, MSHA pilus components are projected to be encoded within three distinct genetic
operons; an assembly operon (msh-I), a structural operon (msh-II), and a retraction operon (pilTU). However,
little is known about how these msh operons are expressed or regulated. Given that proper regulation of MSHA
pilus expression/production is vital for not only environmental survival, but for host colonization and infection, the
goal of my research group is to define mechanisms and regulatory pathways that mediated MSHA pilus
production to facilitate these vital niche transitions during the V. cholerae lifecycle. An initial screen for regulators
of MSHA production, identified the fatty acid metabolism regulator protein FadR as a putative positive regulator
(enhancer) of msh-I operon expression under environmental conditions. Enhancer activity of FadR is negatively-
controlled by exogenously-derived long-chain fatty acids (LCFAs), which are a large component of the
mammalian diet, and can readily be taken up from the environment by V. cholerae. Our preliminary data
demonstrates that both deletion of fadR and supplementation of known FadR LCFA ligands, significantly
diminishes msh-I operon expression. Our working hypothesis is that FadR promotes expression of the msh-I
operon to facilitate MSHA pilus production and surface colonization under environmental conditions, and that
host-derived LCFAs suppress FadR enhancer activity to down-regulate MSHA production and promote V.
cholerae host colonization and infection. This proposal seeks to address this hypothesis, through two specific
aims. In Aim 1, we will characterize the promoter regions of the msh operons, and evaluate FadR-mediated
regulation of msh-I operon expression and MSHA pilus production. We will then seek to assess the role of FadR
LCFA ligands on the regulation of FadR enhancer activity of msh-I expression, MSHA pilus production, and V.
cholerae surface colonization and biofilm formation as a part of Aim 2. The outcome of this work will elucidate a
novel host-responsive regulatory mechanism that facilitates transitions in niche colonization during the V.
cholerae lifecycle, and could lead to the development of strategies for attenuation of V. cholerae environmental
persistence and/or host infectivity.

Public health relevance
PROJECT NARRATIVE Production of the type IV mannose-sensitive hemagglutinin (MSHA) pilus is essential for biofilm formation and environmental survival of the pandemic cholera pathogen Vibrio cholerae, yet is detrimental to host colonization and establishment of infection. These proposed studies will define a novel msh transcriptional regulatory mechanism that facilitates the transition of V. cholerae from colonization of the environment to the host. Information obtained from these studies could be leveraged to the development of new strategies to prevent either environmental persistence or host pathogenesis of V. cholerae.